Administrative Core

ADMINISTRATIVE CORE
PROJECT SUMMARY
The Administrative Core of the “Immunobiology and Immune Therapy for Merkel cell carcinoma” P01 provides
overall direction, coordination of the Scientific Advisory Board meetings, as well as administrative, regulatory
and fiscal oversight to the three Projects and the three Shared Resource Cores (Biostatistics & Bioinformatics,
Immunophenotyping, and Specimen & Data). The Administrative Core will provide an effective organizational
structure to expedite research and promote communication between Program Project components and
investigators and the scientific and patient communities. The Administrative Core is responsible for strategic
planning, as well as effective organizational structure among the performance sites (Fred Hutchinson Cancer
Research Center, University of Washington, and Seattle Cancer Care Alliance). The Administrative Core is
responsible for research effort coordination and allocation of NIH funds. This Core will also manage fiscal
components of the Program Project including reallocation of funds to optimize overall function, and resolution
of potential conflicts in a fair and equitable manner to maximize progress of the Program. The Administrative
Core is responsible for communication including dissemination of information relevant to the Program via
email, GoToMeeting teleconferences, as well as in-person meetings. In addition, The Core will provide
strategic outreach to the patient, physician, and scientific communities through maintenance of the
merkelcell.org website (which reaches 100,000 unique users each year), coordination with our MCC patient
advocates, and organization of the MCC Multicenter Interest Group annual meeting. The mission of this Core
is to ensure regulatory and administrative compliance including reporting to the Scientific Advisory Boards and
NIH as well as to support and sustain optimal efficiency of the Projects and Cores of the Program.